Bi-directional neural interface for probing parallel visual pathways

Project Summary/Abstract
The goal of this proposal is to develop a high-fidelity adaptive electrical interface to the retina and use it to
investigate the contributions of the parallel visual pathways (M and P, ON and OFF) to the perception and
behavior of macaque monkeys. The device will operate bi-directionally at the resolution of single cells and
single spikes, and will adapt itself to the diversity of cell types and locations in the host neural circuitry.
We build on our extensive work in isolated primate retina, which demonstrates the ability to electrically
stimulate and record nearly complete populations of retinal ganglion cells at single-cell, single-spike
resolution. We will develop the technologies needed to take this approach to the in vivo setting, and then
use them to probe visual function in behaving macaques, by pursuing three aims: (1) develop and test a
high-density, large-scale electrical recording and stimulation device, (2) develop surgical techniques, test
biocompatibility, and test functionality in anesthetized animals, and (3) probe the computations within and
between the M and P pathways and their role in motion vision. Our unique approach to these problems
relies on a team with extensive experience in neurophysiology, visual behavior, integrated circuits,
materials science, surgery, and signal processing. In addition to testing fundamental aspects of visual
function in novel ways, this work will produce a platform technology for other neural interfaces and a
functional prototype for a future retinal implant to treat incurable blindness.

Public health relevance
Project Narrative The goal of the proposed work is to develop a high-fidelity, adaptive electronic interface to the nervous system, capable of interfacing to large populations of neurons at cellular resolution, and use it to probe the function of the parallel visual pathways in behaving animals. The technology will be developed by a team with expertise in neurophysiology, visual behavior, electrical engineering, materials science, surgery, and computation. This platform technology will be used to probe fundamental questions about the function of the early visual pathways, and will be generalizable to a wide variety of scientific and clinical applications.